BLRD Research Career Scientist Award Application

The overarching theme of my current research is to understand how growth hormone (GH) and insulin-like
growth factor I (IGF1) regulate adult metabolic function and how dysregulation of GH/IGF1 production and
signaling contributes to the progression of metabolic disease, as well as related tissue injury and repair. A major
focus of my work is to understand the etiology of non-alcoholic fatty liver disease (NAFLD). NAFLD represents
a spectrum of excess fat accumulation in the liver (steatosis) without or with inflammation/fibrosis (non-alcoholic
steatohepatitis - NASH). NAFLD is commonly observed in obesity and type 2 diabetes, but is also observed in
non-obese patients associated with cardiovascular disease, where all diseases are more prevalent in Veterans,
compared to the general population. NASH increases the risk of developing liver cancer, and is now recognized
as the leading cause for liver transplantation. Dietary fatty acids (FA) and FA derived from adipose tissue
lipolysis, due to systemic insulin resistance, are major contributors to NAFLD. In addition, enhanced hepatic de
novo lipogenesis (DNL) contributes to NAFLD. Clinical and experimental studies show NAFLD is associated with
reduced GH-signaling (reflected by low plasma GH and hepatic GH resistance, leading to low IGF1 levels). The
reduction in GH-signaling may exacerbate NAFLD, based on studies showing SNPs within the GH / GH receptor
(GHR) /JAK2 / Stat5 signaling pathway are associated with NAFLD. Also, increasing GH can reduce NAFLD in
both humans and mice.
We have reported that adult-onset loss of hepatocyte GH signaling (aHepGHRkd; GHRfl/fl mice treated with an
adeno-associated viral vector expressing thyroxine binding globulin promoter driven Cre [AAV8-TBGp-Cre]) led
to the rapid development of steatosis, associated with an increase in DNL (Cordoba-Chacon et al., Diabetes
2015). Of translational relevance, hepatic DNL/steatosis after aHepGHRkd is sustained with age and associated
with hepatocyte ballooning, inflammation and fibrosis (hallmarks of NASH; Cordoba-Chacon et al.,
Endocrinology 2018). Studies outlined in my current R01 take a multi-level approach to define the
biochemical/molecular mechanisms by which hepatocyte GH-signaling directly controls glycolysis-driven DNL
and steatosis, by manipulating hepatocyte GH signaling in mice by hepatocyte-specific, AAV-vector delivery of
transgenes within the GH-signaling pathway then assessing; gene and protein expression of enzymes in
glycolytic and lipogenic pathways, fatty acid composition by GC/MS, glycolytic flux and TCA cycle intermediates
under hyperinsulinemic:hyperglycemic clamps, using stable isotope tracers. Studies outlined in my current
BL&RD VA Merit are focused how the reduction in hepatocyte GH signaling contributes to diet-induced NASH
and how reconstitution of the GHR signaling pathway (specifically Stat5b activity and/or IGF1 using AAV vector
delivery) may prevent and/or reverse steatosis and liver injury. To date we have exciting preliminary data
suggesting, hepatocyte GH-signaling works independently of Stat5b/IGF1 to suppress hepatic DNL, while Stat5b
is critical to protect the liver from diet-induced injury. These protective effects may extend to other types of liver
injury including those induced by environmental toxins (focus of CACHET pilot award).
In addition to assessing the role of GH/IGF1 in protecting the liver from injury, in collaboration with Timothy
Koh, PhD (UIC, wound healing expert) we are exploring the role of IGF1 in regulating diabetic wound healing.
These studies are funded by a RR&D VA Merit and examine the basic mechanisms of wound healing in mouse
models of insulin-resistance (diet-induced) and diabetes (db/db) with or without hepatic IGF1 production. Studies
will also examine if low-intensity vibration patches (developed and optimized by Onur Bilgen PhD, Rutgers) can
speed wound healing via enhanced IGF1 production/actions. Taken together, these basic studies will help to
identify unique targets that can be used to develop treatment strategies, in order to prevent the deleterious
consequences of obesity/diabetes, which are commonly found in the Veteran population.

Public health relevance
Growth hormone (GH) and insulin-like growth factor I (IGF1) are critical for body growth from birth through puberty. In adults, GH and IGF1 also control metabolism and may help the body repair after injury. GH and IGF1 are reduced in obese and diabetic patients. The reduction of GH and IGF1 may contribute to more weight gain, increase the severity of diabetes and cause fat to build up in the liver, ultimately leading to liver injury (referred to as non-alcoholic steatohepatitis [NASH]). NASH increases the risk of developing liver cancer and is now recognized as the leading cause for liver transplantation. In addition, the reduction in IGF1 may contribute to poor wound healing observed in diabetic patients. Work conducted in my laboratory explores the possibility that enhancing GH or IGF1 action may protect against the development of NASH and speed wound healing. These basic studies may reveal unique targets that can be used to develop therapies to treat the consequences of obesity and diabetes, which are common in Veterans.